Influence of Orexin Antagonism on Opioid and Methamphetamine Demand

PROJECT SUMMARY ABSTRACT
Deemed a “Twin Epidemic” or “Fourth Wave”, epidemiological evidence emphasizes rapidly increasing public
health harms of methamphetamine use among people who use opioids. These data are particularly worrisome
given there are no FDA approved pharmacotherapies for methamphetamine use or established treatments for
methamphetamine/opioid co-use. A promising target for the regulation of stimulant and opioid motivation is the
orexin system. Preclinical and early clinical findings suggest that orexin system antagonism is a clinically viable
approach to selectively reduce motivation for both opioids and stimulants. Human laboratory data are needed to
investigate this mechanism and extend it to a co-use setting. This project will address this gap by using a
behavioral economic demand framework to evaluate motivation for use of opioids, methamphetamine, and their
combination in people with opioid use disorder. Demand analyses will directly inform the direction of subsequent
treatment studies by identifying motives for opioid-methamphetamine co-use and determining whether these
drugs act as substitutes (i.e., as consumption of one decreases, consumption of the other increases), which
would necessitate treatments that target both drugs to avoid breakthrough use, or as complements (i.e., as
consumption of one decreases, consumption of the other decreases), which would support treatments that target
one drug to concomitantly decrease use of the other. This is an optimal approach that will inform more
expeditious development of treatment trials and reduce risk of inducing harm with identification of incorrect
targets. We will conduct a residential human laboratory study with non-treatment seeking participants with opioid
use disorder. Participants will complete sessions with blinded administration of oral methamphetamine,
oxycodone, their combination, and placebo. Validated demand measures sensitive to pharmacological
manipulation will determine own-price demand (commodity alone) and cross-commodity demand (concurrent
commodities). Participants will be randomized to receive oral suvorexant or placebo throughout the residential
stay. We hypothesize that orexin antagonism will result in higher demand elasticity (lower drug use motivation)
for methamphetamine, oxycodone, and their combination. We also hypothesize that the majority of participants
will show a demand response in which methamphetamine serves as a substitute for oxycodone use, suggesting
that treatments will be needed to target both drugs to avoid breakthrough use. Secondary analyses will evaluate
sleep disturbances on non-session days and days in which study drug (methamphetamine, oxycodone, or their
combination) is administered and we hypothesize fewer sleep disturbances in the suvorexant condition. This
work will use translational laboratory methods to evaluate pharmacological and behavioral mechanisms
underlying opioid, stimulant, and co-use motivation, providing insight into and treatment directives for a co-use
trend of increasing public health harm.

Public health relevance
NARRATIVE Rapidly increasing public health harms of methamphetamine use have been observed among people who use opioids underscoring the need for information on mechanisms underlying motivations for use to inform treatment development. The goal of this project is to rigorously evaluate orexin system regulation of opioid and methamphetamine use and co-use using a behavioral economic demand framework. The proposed project will provide key insights into pharmacological and behavioral mechanisms underlying methamphetamine and opioid use and co-use to guide expeditious development of novel treatments.